Exploration of the oropharyngeal resistome as a reservoir of antimicrobial resistance in Neisseria gonorrhoeae

Project Summary/Abstract
Gonorrhea is one of the most common sexually transmitted infections (STIs) globally, and prior to the COVID-
19 pandemic, the second most common reportable infection in the U.S. In the past decade, there have been
significant increases in gonorrhea among men who have sex with men (MSM) in the US, with a 375% increase
observed from 2010–2018. At the same time, the percentages of antimicrobial-resistant Neisseria gonorrhoeae
(AMR-NG) continues to increase markedly in MSM. Despite the significant increase in the prevalence of AMR-
NG, the drivers and reservoirs of AMR-NG especially for oropharyngeal gonorrhea commonly diagnosed in MSM
and responsible for all the reported cases of failed ceftriaxone treatment are yet to be fully elucidated. The
oropharynx is reservoir for AMR-NG because it harbors a large microbiota and repertoire of AMR genes. The
overall goal of this proposal is to describe comprehensively the oropharyngeal resistome of men who are a
priority population for STI and HIV control and prevention. In Aim 1, we will use culturomics to identify NG and
commensal bacteria, determine their AMR profiles, and use the phenotypic AMR data for stringent quality control
of our oropharyngeal resistome profiling (Aim 2). In Aim 2, we will use an unbiased culture-independent
metagenomic sequencing and comprehensive bioinformatic analysis to determine the oropharyngeal resistome
of MSM and MSW. In Aim 3, we will sequence 150 commensal Neisseria spp. paired with NG isolates obtained
from the same patient when isolated (Aim 1) to demonstrate that they share the same genetic markers of AMR.
We will define the genetic mechanisms of AMR among multidrug-resistant (MDR) commensal Neisseria spp.,
and investigate the relative frequency of in vitro transfer of AMR from 10 different species of commensal
Neisseria to fully susceptible and genetically diverse recipient strains of NG. We expect that the results from
these studies will provide urgently needed data on the repertoire of AMR genes and genetic determinants
facilitating the evolution of NG resistance to antibiotics recommended for gonorrhea treatment including
ceftriaxone, the last remaining highly effective treatment option for gonorrhea, and paving the way for improved
proactive identification and mitigation of emerging AMR threats. Our data will immediately contribute to the
surveillance of AMR threats in MSM disproportionately impacted by gonorrhea and HIV epidemics, and guide
efforts to develop novel antimicrobials for combatting MDR-NG.
Public Health Significance. This study will define the magnitude and diversity AMR in the human oropharynx,
an anatomic site thought to play a central role in the emergence of AMR-NG, and will provide new insights into
which bacteria and under what circumstances NG may acquire AMR. This knowledge will provide important
insights into how AMR-NG develops, critically important information in developing strategies to contain the threat
of AMR-NG and for development of novel antimicrobials.

Public health relevance
Project Narrative The oropharynx is an underappreciated reservoir for antimicrobial resistance (AMR) in Neisseria gonorrhoeae (NG) because it harbors a diverse microbiota with a large repertoire of AMR genes and mutations, and facilitates horizontal genetic exchange of AMR determinants between NG and the commensal bacteria. In this important study, we propose to elucidate the oropharyngeal resistome of men with greater incidences of gonorrhea and AMR- NG using complementary metagenomic and culture-based approaches. We hypothesize that oropharyngeal resistome profiling will be an effective pharyngeal gonorrhea control strategy, provide early warning system to circumvent the emergence of new AMR mechanisms in NG, enhance NG AMR surveillance, and support the development of novel antibiotics for AMR-NG.